ACTH-CORTISOL SECRETION AND SLEEP CHANGES IN DEPRESSION

Fifteen depressed pts and 15 normals will have HPA testing (basal and dynamic using metyrapone and dexamethasone) of glucocorticoid regulation. We will relate neuroendocrine and sleep-EEG findings. Goals include prevalence of altered pulsatile and circadian hormone secretion, and nature of impairment of their minute-to-minute secretory bursts and clearance rates.